Leveraging Vulnerabilities Induced by STING Activation in Pancreatic Cancer

PROJECT SUMMARY/ABSTRACT
Stimulator of interferon genes (STING) is an emerging target for the treatment of solid tumors. Investigations of
the therapeutic relevance of STING agonists have primarily focused on the immunomodulatory effects
mediated by STING-activation dependent induction of type I interferons (IFN) in the tumor microenvironment.
However, how IFN signaling induced by STING agonists impacts malignant cell signaling and metabolism is
poorly understood and, whether these effects can be therapeutically exploited has not been investigated. Data
are presented showing that STING is highly over-expressed in pancreatic ductal adenocarcinoma (PDAC) and
that its activation in PDAC malignant cells results in impaired tumor growth in an IFN-signaling dependent
manner. Thus, elucidating the consequences of STING-driven IFN signaling is particularly relevant in PDAC
which is the third-leading cause of cancer-related mortality in the U.S. with an overall survival of less than one
year. Preliminary metabolomic and proteomic analyses point to two major interconnected biochemical
processes impacted by IFN signaling in PDAC cells: (i) nucleotide metabolism, which is evidenced by the
depletion of deoxyribonucleotide triphosphate (dNTP) and nicotinamide adenine dinucleotide (NAD) pools; and
(ii) activation of the DNA replication stress response signaling pathway mediated by Ataxia Telangiectasia and
Rad3-related protein (ATR). This proposal is designed to test the hypothesis that STING-driven dNTP and
NAD depletion in malignant cells result from the transcriptional upregulation of SAM domain and HD domain-
containing protein 1 (SAMHD1), a powerful dNTP phosphohydrolase, and of specific members of the poly-
ADP-ribose-polymerase (PARP) family (PARP9/10/14) which increase NAD consumption, respectively. It will
further test the hypothesis that malignant cells engage specific adaptive mechanisms to counteract these
metabolic alterations and that their inhibition will synergize with STING agonists. Studies in Aim 1 will
investigate the consequences of STING activation in orthotopic PDAC cell line and patient-derived xenograft
models from a pre-existing repository and will investigate mechanistic links between STING activation and
replication stress. Studies in Aim 2 will test rationally designed combination therapies that block two major co-
dependencies elicited by STING activation in PDAC cells: (i) the ATR-regulated replication stress response
and (ii) nicotinamide phosphoribosyltransferase (NAMPT)-mediated nicotinamide recycling. Studies in Aim 3
will employ immunocompetent implantation and autochthonous PDAC models to test the concept of targeting
co-dependencies identified in Aims 1 and 2 in the context provided by ongoing clinical trials in which STING
agonists are combined with immune checkpoint blockade. Collectively, studies proposed in this application are
designed to increase the understanding of the interplay between STING signaling, nucleotide/NAD metabolism
and replication stress response in PDAC with the ultimate goal of uncovering critical vulnerabilities to be
exploited by new therapeutic approaches against this extremely aggressive and difficult to treat malignancy.

Public health relevance
PROJECT NARRATIVE STING agonists are a promising anticancer treatment currently being explored in pancreatic ductal adenocarcinoma (PDAC), a disease which is notoriously resistant to current therapies. A systematic metabolomic and proteomic proﬁling identiﬁed previously unappreciated consequences of STING activation in PDAC malignant cells, speciﬁcally the depletion of nucleotide pools and activation of the replication stress response pathway. This proposal will examine mechanistic underpinnings of these observations and will test rationally designed therapies with the goal of deﬁning new therapeutic options for PDAC for future clinical translation.